Leadership, Planning and Evaluation

ABSTRACT
Moores Cancer Center (MCC) has a strong leadership structure and robust planning and evaluation procedures
to ensure that the Center’s vision and goals are met, led by a Senior Leadership team with well-defined roles to
foster collaborative, multi-disciplinary, translational efforts. Led by Scott Lippman, this team includesa Deputy
Director and Associate Directors for Clinical Sciences, Population Sciences, Disparities, and Community
Engagement; Basic Science; Shared Resources; Research Education and Training; and Administration. These
Senior Leaders are all located in the MCC building, which greatly facilitates interaction and collaboration.
MCC’s 5 Research Programs are co-led by experienced researchers with complementary expertise, who
advise the Director to help guide MCC operations in areas such as faculty recruitment, program organisation,
priorities for developmental funds, and MCC membership.
MCC has well-organized structures that create an efficient process through which the Center can effectively
plan, decide, monitor, adjust, and allocate resources, and respond to opportunities and changes in the
research environment. An Executive Committee made up of Senior Leaders, consortium partner
representatives, and clinical leaders of medicine, surgery, radiation oncology and pathology, and with ad-hoc
attendance by the Dean and CEO serves as a senior advisory body to the Director and oversees operations of
the following 4 committees: 1) a Senior Leaders Council that plays a vital role in planning, monitoring, and
evaluating MCC; 2) a Shared Resources (SR) Oversight Committee that optimizes the ability of SRs to provide
high impact, cost-effective support for MCC research; 3) a Pilot Grant Review Committee, and 4) a Space
Advisory Committee. In addition, the MCC External Advisory Board (EAB) plays a key role in MCC’s planning
and evaluation process.
Our new Strategic Plan, developed in 2018, provides the vision, goals, scientific foci as well as tactics,
strategies and resources for continued growth and impact. Our strategic goals, which are to: 1) advance
excellent patient outcomes through innovation, education, and patient-centered care, 2) reduce cancer risk and
improve survivorship by changing at-risk behaviors, 3) support outstanding basic, translational and clinical
research programs to optimize translation of discoveries into novel treatments, 4) discover, develop and apply
cutting-edge, individualized cancer treatments that optimize response, minimize toxicity and improve survival,
5) build outstanding research infrastructure including state-of-the-art Shared Resources to support exemplary
basic, translational, clinical and population-science research, and 6) strengthen engagement and collaboration
of faculty, staff and students with the community; reflect an emphasis on the clinical research arena, which will
generate the greatest return in translating laboratory progress and improving treatments for cancer patients
and cancer prevention for at-risk individuals.